Dynamic DNA Structures in Biology

This proposal requests partial support for the FASEB Summer Research Conference on Dynamic
DNA Structures in Biology, which will be held July 21-26, 2024, in Melbourne, Florida. DNA forms a
variety of non-canonical structures that are important for the proper regulation of essential
molecular processes such as replication, recombination, and transcription. However, these
structures can also promote mutation of repetitive regions and other DNA sequences, resulting in
more than 30 inherited disorders. Recent advances in the field have led to new insight into how
environmental factors and endogenous cellular processes promote DNA structure changes, and the
involvement of dynamic DNA structures in human disease. The long-term goal of this conference is
to understand the mechanisms by which DNA structures form, are resolved, and create genomic
instability, with emphasis on their relationship to diseases and the development of potential
therapies. Our aims are to explore recent research relevant to DNA structural transitions, to
highlight new discoveries and technologies in the field, to promote the career development of
trainees and young investigators, and to establish a conference culture that will lead to new
collaborations. To this end, we will bring together ~100 participants for five focused and highly
interactive days of science. The program will include an opening keynote talk, ten scientific
sessions, and informal poster sessions. Emphasis will be placed on new technologies, including
computational and single molecule biophysical analyses, that can analyze the effects of cellular and
environmental factors on DNA structure formation and resolution. In response to feedback from the
previous conference, we will have new sessions this year on novel technologies for the analysis of
dynamic DNA and the roles of structured DNA in transposable elements, viruses, and parasites.
Nearly one-third of the talks will be chosen from submitted abstracts, with preference given to junior
investigators, trainees, and new conference attendees. Other new features are the purposeful
inclusion of several industry experts as invited speakers and the use of discussion leaders to
synthesize the state of the field at the beginning of each session. These changes will support the
uniqueness of the Conference in bringing together scientists from diverse fields with a common
focus on dynamic DNA transitions and provide a supportive and interdisciplinary environment in
which new investigators and trainees can interact with field leaders to share their findings and
develop new collaborations.

Public health relevance
DNA forms a variety of non-canonical structures that are important for the proper regulation of molecular processes such as replication, recombination, and transcription, but these structures can also promote mutagenesis, driving disease states. This conference will focus on the mechanisms by which DNA structures form, mutate, and resolve, with emphasis on new technologies that can analyze the effects of cellular and environmental factors on different DNA structures. In addition, the conference will provide a supportive and interdisciplinary environment in which new investigators and trainees can interact with field leaders to share their findings and develop collaborations, leading to new therapeutic approaches.